Pre-Eclampsia: Factors conferring Risk and Protectionn in Minority Women w/Dysgl

PROJECT SUMMARY (See instmctions): Pre-eclampsia (PE), characterized by ofe novo hypertension and proteinuria during pregnancy, is a major cause of maternal and fetal death, and the leading cause of premature delivery worldwide. Currently there is no effective treatment, and delivery of the baby is the only

Public health relevance
RELEVANCE (See instructions): Understanding the genetic risk factors associated with pre-eclampsia will help researchers focus on potential research to develop treatments to prevent or arrest PE in pregnant women.